TB/MDR-TB Research training and Capacity Strengthening for LMIC in Southeast Asia Phase II: End-of-Fiscal-Year Supplement

Project Summary/Abstract
TB/MDR-TB is a serious global health problem. Southeast Asia is a region heavily affected by this
disease. To achieve the END-TB goal, research on TB must be enhanced.
The objective of our D43TW009522 grant "TB/MDR-TB Research capacity strengthening program for
Southeast Asia, Phase II" is to strengthen TB research capacity, especially human resources for TB
research, at LMIC collaborating research centers and the National TB Control Program (NTP) in
Myanmar, Thailand, and Indonesia.
Since 2015, we have been training a series of young researchers from these three countries effectively.
The trainees were from the collaborating centers, who return to work in their countries successfully.
However, there has been a serious political turmoil in Myanmar in 2021. Research facilities and human
resources are interrupted. Most of our alumni could not continue to work in the country. There is a
need to try different methods, including indirect approaches, to assemble human resources for
research. When the political situation turns more favorable, research in the country can then regain its
momentum.
Two Myanmar alumni of our grant are now working at the Department of Epidemiology as postdoctoral
fellows on TB research. Supporting these scientists to grow further can at least partially maintain human
resources for TB research that D43TW009522 had invested.
At the Department of Epidemiology, Prince of Songkla University (EPI-PSU), TB research projects are
growing to serve the national and global needs. We have been working more intensively with the
Division of Tuberculosis (DTB) than before. Our scope of TB research has expanded to include National
Big Data on the health system, which includes TB. Thailand is going to do routine whole genome
sequencing on all isolates of Mycobacterium tuberculosis. TB control has become more intensive in
screening and treatment of latent TB infections. These national and institutional expansions in TB
research require more well-trained epidemiologists to get involved. Well-trained TB epidemiologists are
therefore needed by both Myanmar and Thailand and other countries.
We are requesting the end-of-year supplement grant to support these two alumni as our postdoctoral
fellows They will work with the senior and junior researchers in developing research proposals, analysis
of existing data, preparing manuscripts, and writing competitive research grants. Two main research
topics to be accomplished by them include post-TB study and analysis of management gap in TB contact
tracing. As PSU is pushing Responsible Conduct of Research policy and practice, they will do research on
join this mission. Under our supervision, they will appropriately join the National TB prevalence survey
and the Project to improve the National TB database.
Professor Virasakdi Chongsuvivatwong, the PI of D43TW009522, will be their main mentor and joined by
the senior faculty members of EPI-PSU and Mahidol University.
Annual evaluation of this post-doctoral training will follow the procedures set by PSU’s Post-doctoral
Program, which emphasizes peer-reviewed scientific publication.

Public health relevance
PROJECT NARRATIVE Disruption of the TB research capacity of Myanmar from political turmoil needs remediation. The current project will train two postdoctoral fellows to continue TB research activities at the Department of Epidemiology, Prince of Songkla University. They will also learn to work with and mentor junior researchers and students. Their competency improvement will enable them to re-accelerate TB Research and control in Myanmar when the situation is improved.